Genetic Variation and Inflammation-Dependent Hematopoietic Regulatory Networks

PROJECT SUMMARY
Transcription factors and cellular signaling mechanisms establish and maintain regulatory networks that allow
the hematopoietic system to respond to infection, inflammation and other stresses. These networks mediate the
expansion, mobilization, and differentiation of hematopoietic stem and progenitor cells (HSPCs). As exemplified
by human germline variation in genes encoding HSPC-regulatory factors, such as GATA2 and RUNX1, genetic
variation can disrupt HSPC activities, leading to recurring infection, cytopenia, and/or bone marrow failure.
However, the mechanisms underlying these defective responses are incompletely understood. We have
modeled human pathogenic variants causing GATA2 deficiency syndrome, where patients present with recurring
infections and cytopenias with progression to MDS and AML. This model utilizes mice with a single-nucleotide
variant from GATA2 deficiency patients, in conjunction with a severely impaired Gata2 +9.5 enhancer in the
second allele (compound heterozygous; CH), mimicking epigenetic silencing and allele-specific expression
correlating with disease presentation. We demonstrated that Gata2 variation alters steady-state HSPC levels,
blocks HSPC expansion and differentiation in response to chemotherapy, attenuates long-term repopulating
activity following bone marrow transplantation, leads to bone marrow failure following chronic inflammation by
the viral mimetic polyI:C, alters HSPC response to the bacterial cell wall component LPS, and attenuates HSPC
mobilization in response to pro-inflammatory cytokines, including G-CSF. We hypothesize that pathogenic
clinical variants disrupt GATA2- and infection/inflammatory-instigated networks essential for HSPC expansion
and differentiation, and we shall utilize global approaches to generate a rigorous foundation for elucidating how
variants impact networks in the context of sterile- and infection-induced inflammation. Aim 1 will develop global
insights into GATA2-dependent mechanisms that regulate HSPCs in response to bacterial infection and sterile
inflammation. Barcoding cell surface markers coupled with single cell RNA-sequencing (CITE-seq), will be
performed on HSPCs to determine pathways altered by the pathogen response, immunophenotypic populations
affected, and how clinical variants disrupt the networks. The contribution of the niche to HSPC function will also
be analyzed. Aim 2 will determine how fungal infection alters networks governing HSPC expansion, mobilization,
and inflammation, and the requirement of GATA2 in these processes. We will generate libraries of differentially
expressed transcripts in HSPC populations following infection with the pathogen Aspergillus fumigatus.
Inflammatory cytokines will be quantified via multiplex cytokine analysis. We will test if networks responsible for
HSPC response to fungal infection remain intact in GATA2 deficiency genetic models. These pilot studies will
leverage existing models to generate systems and omic datasets to elucidate how germline genetic variation
creates a predisposition to bone marrow failure.

Public health relevance
PROJECT NARRATIVE Viral and bacterial infection and associated inflammation drive expansion and differentiation of hematopoietic stem and progenitor cells. These processes can be corrupted by germline genetic variation, which creates a predisposition to bone marrow failure through unknown mechanisms. We will develop systems and address mechanisms to understand how variation impacts infection/inflammation-instigated genetic networks. As fungal infection is common in patients with bone marrow failure and immunodeficiency, understanding the relationship between variation, infection, and hematopoiesis has critical fundamental and clinical/translational implications.